Effect of statin intake on Non-traumatic Generalized Knee Osteoarthritis

In this proposal, we will confirm of statins’ protective effects against knee OA progression statins in subjects with
non-traumatic generalized OA (GOA) with no/minimal subchondral bone marrow lesions (BMLs) as “potential
responders” and investigate the mechanism for statin protective effect on subchondral bone using dyslipidemia-
associated non-traumatic OA mice models. While there is no universal consensus on its definition, GOA is
commonly described as familial with polyarticular involvement and Heberden's nodes (HNs) in hand joints.
Epidemiologic studies have shown that dyslipidemia and atherosclerosis are more prevalent among non-
traumatic GOA (HN+) patients than non-OA subjects. Atherosclerosis may accelerate the GOA (HN+) through
the ischemic effect on subchondral bone. A high-fat diet can also lead to OA-related subchondral bone damage
both in humans and mice. Besides, OA-related bone marrow lesions (BMLs) detected by MRI are strongly
associated with dyslipidemia. Experimental studies using dyslipidemia mice models (e.g., Apolipoprotein E-
deficient (ApoE-/-) mice) have suggested a protective role for statins, first-line lipid-lowering drugs, on
subchondral bone. While experimental animal studies have demonstrated a DMOAD role for statins, the overall
observational clinical evidence for the protective effects of statins on OA outcomes have been inconsistent,
which could be due to: 1) perhaps most importantly, heterogeneous subject selection with regard to OA etiology
and baseline stage; 2) insufficient follow-up time; 3) use of only plain radiographs for OA progression rather than
MRI. Our recently published results showed that only subjects with the presence of HN as the hallmark of non-
traumatic GOA (HN+), but not HN– patients, show the lower hazard of radiographic OA progression compared
to statins nonusers. In our further preliminary analysis of semiquantitative MRI BML measurements, only non-
traumatic GOA (HN+) statin users with no/minimal BML demonstrated a lower risk of BML worsening at a 2-year
follow-up MRI. Based on these results, we hypothesize that statin use has a protective effect on subchondral
bone in non-traumatic GOA (HN+) subjects with no/minimal baseline BML, as “potential responders." Using per-
protocol and incident user design and propensity score (PS) matching for potential confounding by indication
variables (OA and statin indications), a selected subset of OAI participants with non-traumatic GOA (HN+) with
no/minimal BMLs will be used. We further investigate the underlying mechanism in dyslipidemia-associated non-
traumatic OA mice models through inhibiting subchondral bone vascular defects and associated subchondral
bone marrow deformation. We will pursue the following aims: 1) Determine the association between statin use
and protection against MRI, serum, urine biomarkers of cartilage loss, and pain worsening in "potential
responders." 2) Examine the role of MRI-based OA-related subchondral bone changes as intermediary variables
for the protective effect of statins in “potential responders.” 3) Determine the mechanism for statin protective
effect on early subchondral bone change in dyslipidemia-associated early OA mice models.

Public health relevance
PROJECT NARRATIVE This proposal aims to first confirm statins protective effects on the radiographic knee (OA) progression in a subset of Osteoarthritis Initiative (OAI) participants with non-traumatic generalized osteoarthritis (OA) with Heberden's nodes (i.e., HN+ GOA) and no/minimal subchondral bone marrow lesions (BMLs), as the “potential responders” using advanced MRI measures of cartilage structural damage and serum/urine cartilage degradation biomarkers. Second, the mediatory role of subchondral bone morphometry and subchondral BMLs will be assessed for the protective effect statin on radiographic knee OA outcome. We will further explore subchondral bone and vascular structures and analyze the osteogenesis, angiogenesis, and accumulation of senescent cells (SnCs) in subchondral bone in early dyslipidemia-associated non-traumatic OA mice models to evaluate the mechanism underlying the therapeutic effect of statins.